High-throughput functional characterization of MYH7 variants in genome-edited cardiomyocytes

Hypertrophic cardiomyopathy (HCM) is a heritable hypertrophy of the left ventricle that can present as sudden
cardiac death and heart failure. Autosomal dominant missense variants in myosin heavy chain 7 (MYH7) can
cause up to 40% of the familial HCM cases. While accurate interpretation of MYH7 variants can help identify
patients at risk for developing HCM, there are currently ~1700 MYH7 missense variants in ClinVar that are
variants of unknown significance (VUS), creating diagnostic challenges for clinicians and emotional distress for
patients. Furthermore, because clinical guidelines now recommend that all HCM patients undergo genetic
testing, the number of MYH7 VUS is growing rapidly. Deep mutational scanning (DMS) can help address the
VUS problem by determining the functional consequence of thousands of genetic variants in a single
experiment. By generating accurate variant effect maps that define the function of nearly all possible missense
variants in a sequence of interest, DMS can assist with clinical variant interpretation at scale. So far, deep
mutational scans have been primarily practiced in cancer-derived cell lines, which are not helpful for assessing
genes such as MYH7 that are only expressed in specialized cells like cardiomyocytes. Human induced
pluripotent stem cells (hiPSCs) can differentiate to many cell types, offering a solution to this problem;
however, gene-editing in hiPSCs is generally low throughput. We recently developed a novel gene-editing
technique called CRISPR activation On-Target Editing Retrieval (CRaTER) that can edit hiPSCs at scale,
enabling the generation of large variant libraries in hiPSCs for the first time. To address the growing MYH7
VUS problem, we plan to perform a deep mutational scan of the MYH7 S2 domain, a mutational hotspot
associated with HCM, in physiologically-relevant hiPSC-derived cardiomyocytes (hiPSC-CMs). In Aim 1, we
propose to generate a single nucleotide variant (SNV) library encoding nearly all possible MYH7 S2 missense
variants in hiPSC-CMs. We will leverage CRaTER-assisted genome-editing to be able to generate a hiPSC
SNV library at this scale. In Aim 2 we will optimize and validate phenotypic assays to be able to discriminate
hiPSC-CMs expressing pathogenic variants from hiPSC-CMs expressing benign variants. These phenotypic
assays will inform a deep mutational scan of the MYH7 S2 domain that will determine the functional effect of
nearly all possible MYH7 S2 missense variants and generate a variant effect map to assist with clinical variant
interpretation. Finally, we will use the variant effect map generated to help improve the estimated ~130 MYH7
S2 VUS in the Million Veteran Program’s whole genome sequencing cohort. In summary, we will combine
CRaTER, a novel gene-editing technique we developed, with hiPSCs to perform a DMS of MYH7 in genome-
edited hiPSC-CMs. The results will improve the interpretation of hundreds of MYH7 VUS, enable the
interpretation of thousands of possible MYH7 missense variants that may be encountered in the future, and
provide a framework by which deep mutational scans can now be performed in hiPSC-derivatives for the first
time, which we believe will be transformative for the field of variant interpretation.

Public health relevance
Genetic variants in myosin heavy chain 7 (MYH7) is a common cause of hypertrophic cardiomyopathy (HCM), a potentially life-threatening heart disease that affects an estimated 1:500 in the general population that is also prevalent in Veterans. Most of the MYH7 variants are classified as variants of unknown significance, which affects the ability to accurately identify patients at risk for HCM. This proposal will determine the disease- causing potential of thousands of MYH7 variants to better interpret genetic test results for patients and will identify shared mechanisms by which MYH7 variants cause HCM, which may inform potential future therapies.